SWITCHING DURING DEVELOPMENT--CHARACTERIZATION OF THE HUMAN GAMMA GLOBIN GENE

Our aim is to understand mechanisms involved in globin gene regulation, particularly developmental switching. To study regulatory sequences of the globin gene promoter and flanking region, we constructed a series of composite promoters, each containing a fragment from the fetal gamma-globin upstream flanking region joined to a beta-globin promoter. Their function was assessed in stably transformed human K562 cells, an erythroid cell line that expresses the gamma-globin gene but not the beta. A gamma fragment spanning positions -259 and -137 activated the nonfunctional beta promoter in these cells. Further analysis of this 120 bp sequence may identify elements controlling the switching of the fetal gamma-globin gene.